High-throughput Imaging-integrated Vascular Model for Understanding Thromboembolism and Therapeutics Screening

In order to accurately determine the volume concentrations of different molecular components of
the vascularized thrombosis organ-on-a-chip models developed in the parent grant, the proposed
supplement application will focus on building and testing a new imaging technology, which can
acquire the experimental absorption spectra of various tissue components. Specifically, Colton
McGarraugh at the Yao lab at Duke University will develop the ‘photoacoustic fingerprinting’
method, which will be used to identify different concentrations of varying molecules by comparing
a variety of different photoacoustic measurements at different wavelengths and their ‘matched’
models in the simulated library. This new technology will have the potential to identify different
proteins and larger molecules in the engineered tissues of the organ-on-a-chip system beyond
hemoglobin, such as fat, proteins, fibrin, platelets, and glucose, and thus will enhance the
technical capabilities of the photoacoustic imaging technology proposed in the parent grant.

Public health relevance
Project Narrative In order to accurately determine the volume concentrations of different molecular components of the vascularized thrombosis organ-on-a-chip models developed in the parent grant, a new imaging technology will be built and tested thoroughly to properly identify and match experimental absorption curves to known values of the tissue components. Specifically, this project will develop the ‘photoacoustic fingerprinting’ method which will be used to identify different concentrations of varying molecules by their volume by comparing a variety of different photoacoustic intensity values at different wavelengths, and be examined and ‘matched’ to every model in the simulated library. This new technology will have the potential to identify proteins and larger molecules in the engineered tissues of the organ-on-a-chip system, like fat, proteins, fibrin, platelets, glucose and SARS-CoV-2, based on the absorption spectrum for further applications.